Staphylococcus aureus interference with IsdB vaccination

ABSTRACT
Staphylococcus aureus is a leading cause of infection worldwide and a major driver of antibiotic resistance.
Although many staphylococcal vaccines have been developed, all vaccines tested to date in human trials have
failed for unclear reasons. Unlike humans who are infected or colonized with S. aureus at an early age,
laboratory animals are rarely exposed to the human pathogen. Therefore, we queried if prior S. aureus
exposure, in the form of infection, modifies protective immunity conferred by IsdB vaccination. Strikingly, prior
staphylococcal infection in mice interferes with the induction of anti-staphylococcal immunity by IsdB
vaccination. The mechanism appears to be driven by IL-10 and S. aureus-experienced B cells. These findings
led us to hypothesize that S. aureus infection induces an ineffective B cell response associated with IL-10 that
is preferentially recalled when subsequent IsdB vaccine is administered (original antigenic sin). To address
our hypothesis, in Aim 1, we will determine how S. aureus- activated B cells and IL-10 modulate the host
immune response to IsdB vaccine and nullify anti-staphylococcal protection. In Aim 2, we will determine what
modifications to the IsdB-specific antibodies, induced by prior S. aureus exposure, make the antibodies non-
protective. In Aim 3, we will determine the broader clinical relevance of our findings by testing if vaccine
interference occurs in humanized BLT mice and in various clinically relevant settings.

Public health relevance
PROJECT NARRATIVE We have shown in mice that prior exposure to S. aureus abrogates protection conferred by staphylococcal IsdB vaccination, thereby providing a plausible explanation for the failure of the human IsdB vaccine trial. We propose to investigate how S. aureus modulates host immune responses to IsdB vaccination to induce a non- protective antibody response.